Microscope Slide Scanner

PROJECT SUMMARY
This proposal seeks financial aid for acquiring a Zeiss Axioscan 7 high-performance microscope slide scanner to enhance
our research and educational capabilities at Howard University. Currently, our university relies solely on an obsolete
Nikon Ti-E PFS inverted scope, our only operational confocal microscope, which unfortunately offers outdated features
and underperforms. The Axioscan 7, Zeiss's latest advanced imaging system, provides a range of scanning microscopy
capabilities, including fluorescence, brightfield, and polarization microscopy. Its features make it essential for a variety of
applications, especially in biomedical research and education, aligning with our institution's mission to lessen health
disparities and advocate health equity among underrepresented groups. The proposed Axioscan 7 Slide Scanner will be
housed and managed by the Howard University Imaging Core (HUIC), a facility with over 25 years of experience in
leading preclinical imaging research on campus. The HUIC will maintain a dedicated lab for the scanner, employing
experts for supervision, training, and maintenance. The HUIC Special Purpose Fund will handle its long-term
administrative requirements. This setup encourages interdisciplinary collaborations, provides cost savings for individual
grants and investigators, stimulates budding scientists with advanced imaging, and facilitates understanding of diseases
predominantly affecting minority and disadvantaged groups. Our Major and Minor Users, many already funded by the
NIH, eagerly await the Axioscan 7 for their research and educational initiatives. The scanner will expedite studies in areas
such as traumatic brain injury, the effects of opioids on respiratory depression, gene delivery of immunotoxin in head and
neck carcinoma, congenital cytomegalovirus, Zika virus, among others. For education, it will offer invaluable hands-on
experience to students in advanced imaging techniques, AI-assisted histopathological analysis, and a summer oral health
program. This project has full institutional supports for housing, personnel, and additional management funds, if required.
Its use and maintenance will be overseen by the Equipment Oversight Advisory Committee. The Axioscan 7 acquisition
will fortify our research infrastructure, attract more academic professionals and students, foster racial equity in STEM,
and resonate with Howard University's commitment to improving minority health outcomes via enhanced contributions to
health sciences.

Public health relevance
PROJECT NARRATIVE The proposal outlines a requisition plan for a Zeiss Axioscan 7 Slide Scanner for the Howard University Imaging Core. This advanced instrument enables precise, high-throughput analysis of histological samples, catalyzing groundbreaking discoveries in biomedical research. It significantly enhances our institution's research capabilities and improves the quality of education in addressing health disparities and promoting equity among underrepresented groups.